Improving utilization of guideline directed medical therapy and structured exercise interventions in individuals with intermittent claudication in a rural setting

This research aims to improve utilization of guideline-directed medical therapy (GDMT) and structured
exercise therapy (SET) for individuals with intermittent claudication due to peripheral artery disease (PAD)
in rural settings. Despite strong evidence supporting comprehensive care including pharmacotherapy, risk
factor modification, and exercise interventions, these treatments remain critically underutilized, with fewer
than 50% of patients receiving GDMT and less than 10% participating in SET. While barriers to
implementation have been identified in urban settings, little is known about the unique challenges facing
rural patients with PAD. The project employs a multi-method approach with three specific aims: (1) identify
the population of PAD patients in northern New England who are or are not receiving comprehensive
evidence-based claudication management through electronic health record data analysis; (2) assess
facilitators and barriers to GDMT and SET through semi-structured qualitative interviews with both patients
and providers; and (3) evaluate the feasibility and acceptability of a commercially available mobile appbased
structured exercise program among individuals with claudication in rural communities. The research
will utilize expertise from the Center for Rural Health Care Delivery Science, the Dartmouth Center for
Program Design and Evaluation, and the Dartmouth Center for Implementation Science to ensure
methodological rigor and contextual relevance.
The project introduces several innovative elements to address rural healthcare challenges, including
development of a computable phenotype to consistently identify patients with claudication from electronic
health record data, creation of a novel interview guide to explore the unique barriers and facilitators in rural
settings, and systematic evaluation of mobile health interventions in this population. Implementation
science frameworks and methodologies are central to this work, particularly the use of the Consolidated
Framework for Implementation Research (CFIR) to guide the evaluation of the mobile health intervention.
The project will assess implementation outcomes including acceptability, adoption, feasibility, and fidelity of
the intervention, providing valuable insights into the contextual factors that influence implementation
success in rural settings. Through rigorous implementation science methods, the findings will bridge the
gap between evidence-based practices and their real-world application in rural healthcare delivery systems,
addressing one of the most persistent challenges in cardiovascular care.